The Contribution of Late Onset Unexplained Epilepsy to Cognitive Decline and its Interaction with Vascular and Alzheimer's Disease Pathologies

Project Summary
As life expectancy increases, the burden of seizures in the elderly will increase with up to half of the cases with
no identifiable cause termed Late Onset Unexplained Epilepsy (LOUE). Large databases have identified
patients with LOUE as having a higher risk of dementia and stroke, but studies focusing on individual patients
have been limited. There is a current need to identify the factors underlying LOUE, their impact on cognition
and its natural history to develop preventive and therapeutic strategies.
The first goal of this project is to determine the burden of the two most common aging pathologies in a cohort
of LOUE by assessing the burden of small vessel ischemic disease using MRI and blood biomarkers of
Alzheimer’s disease (AD), and how they relate to cognition and neurodegeneration. The second goal is to
follow the LOUE cohort over a 3-year period to determine whether the burden of the pathologies increases
when someone has seizures and leads to accelerated cognitive decline and neurodegeneration. Through a
junior investigator grant funded by the American Epilepsy Society, I have started recruiting a cohort of 40
subjects with LOUE for cross-sectional analyses. As part of the proposed K23, I will expand this cohort to 100
subjects and follow it longitudinally. A control group will consist of subjects from the Harvard Aging Brian Study,
an NIH funded study following cognitively normal (at enrollment)older adults with clinical assessments, fluid
biomarkers, and multimodal neuroimaging, of which my mentor, Dr. Gad Marshall, has been a co-investigator
since its inception. Findings from this study can be applied to other diseases where seizures are a common
comorbidity such as Alzheimer’s disease.
My training will rely on the mentorship of Dr. Marshall (an expert in AD and aging) and Dr. Page Pennell (an
expert in epilepsy), as well as an advisory committee of world leaders in the fields of AD biomarkers (Dr.
Dennis Selkoe), neuroimaging (Dr. Steven Stufflebeam), neuropsychology (Dr. Rebecca Amariglio), vascular
related cognitive impairment (Dr. Anand Viswanathan), and statistical analysis of longitudinal studies (Dr.
Joseph Locascio). During the training period, I will gain expertise in neuroimaging analysis, the implementation
of longitudinal studies in an elderly cohort, and the statistical analysis of longitudinal data. The institutional
resources available through Brigham and Women’s Hospital, Massachusetts General Hospital, Harvard
Medical School, and Harvard School of Public Health are world class and will support my career development
in an environment that can foster high impact contributions. Upon successful completion of the project, I will be
well positioned to launch a career as an independent investigator examining the interactions of seizures,
neurodegeneration, cerebrovascular disease and cognition.

Public health relevance
PROJECT NARRATIVE Epilepsy can be the harbinger of the aging brain and the third most common neurological disorder in the elderly with up to half of new onset cases with no identifiable cause. This work seeks to understand the causes and cognitive trajectory of late onset unexplained epilepsy (LOUE) by exploring the burden of Alzheimer’s disease and cerebrovascular markers and whether epilepsy related factors worsen these pathologies and cause accelerated cognitive decline. This area of research is especially relevant given the aging population and the importance of identifying treatment targets that can prevent and treat LOUE, and the work’s findings can be applied to diseases where seizures are a common comorbidity such as Alzheimer’s disease.